Center for Solutions for ME/CFS

Overall
Abstract
The Center for Solutions for ME/CFS (CfS for ME/CFS) is an inter-disciplinary, inter-institutional center
comprised of clinicians, clinical investigators, basic scientists who are committing to working together to
understand the pathogenesis of ME/CFS and develop evidence-based strategies for interventions that prevent
and mitigate disease. The team initially coalesced with an NIH call to respond to spurious reports linking
xenotropic murine leukemia virus-related virus (XMRV) to ME/CFS. It consolidated its vision with support from
the Hutchins Family Foundation Chronic Fatigue Initiative (CFI) and a crowd-funding organization, The Microbe
Discovery Project, to explore the role of infection and immunity in disease and identify biomarkers for diagnosis
through functional genomic, proteomic, and metabolomic discovery. The foundation for this project is a large
clinical database and sample repository representing oral, fecal, and blood samples from well-characterized
ME/CFS subjects and frequency-matched controls collected nationwide over a period of several years. In
Project 1, we survey for the presence of molecular footprints of bacterial, fungal, and viral agents and
corresponding immune responses in a 100 case/100 control subset of repository samples using high
throughput sequencing, high density peptide arrays, and immune signature assays; this Project also examines
the prevalence of autoantibodies selected based on clinical and literature reports. In Project 2, we profile the
plasma metabolome and PBMC transcriptome in the same subjects studied in Project 1 using state-of-the-art
mass spectrometric and RNA-seq methods, comprehensive mass spectral libraries, and tools for RNA profiling
in bulk cell populations using cell sub-type specific markers. We also pursue metabolomic and transcriptomic
analyses after orthostatic and exercise challenges using samples collected in Project 3. In Project 3, we mine
existing databases at Columbia and the CFI for insights into clinical features, comorbidities, and sub-types that
can be used to refine laboratory analyses, as well as enhance patient care. We will work with clinicians and the
ME/CFS community to design a mobile app that will allow patients and caregivers to track clinical status in
response to stressors and interventions, and will provide prospective research data. We will also investigate
the utility of the Lean Test as a simple outpatient test for autonomic function.

Public health relevance
Overall Narrative The Center for Solutions for ME/CFS is a multi-institutional, inter-disciplinary research center dedicated to understanding the biology of ME/CFS and developing diagnostic tests and methods for preventing and treating disease. It builds on decades of work by a network of expert clinicians and laboratory scientists with expertise in epidemiology, infectious disease, immunology, genetics and biochemistry, as well as a large cohort of well- characterized patients and biological samples. Our efforts will be linked with those of other Collaborative Research Centers and guided by close interactions with the ME/CFS community.